Interdisciplinary Training Program in Metabolism (UCLA-ITPM)

UCLA Interdisciplinary Training Program in Metabolism
PROJECT SUMMARY
The goal of the UCLA Interdisciplinary Training Program in Metabolism (ITPM) is to train the next
generation of investigators who will advance prevention, treatment, and clinical care for metabolism-related
diseases. The UCLA-ITPM seeks to support and train up to 6 scientists for a 2-year appointment. Research
training will be supported by a core curriculum in metabolism and disease pathobiology, grant writing, ethics,
and strategies for successful transition to independence. The UCLA-ITPM is grounded in a collaborative ethos
across scientific disciplines that promotes unique training and educational opportunities. Mentored research
opportunities span basic and mechanistic investigation and translational studies in humans, including 4 areas
of research focus: Integrative Systems Metabolism, Endocrine Action, and Diabetes Intervention; Metabolic
Tissue Phenotypes and Communication Axes/Organelle Biology; Signal Transduction and Energetics; and
Cellular Systems and Intermediary Metabolism.
The ITPM is bolstered by a strong UCLA infrastructure with participating centers/institutes, including the NIH
P30 UCSD-UCLA Diabetes Research Center, Broad Stem Cell Research Center, Goodman-Luskin Microbiome
Center, UCLA Comprehensive Liver Research Center, UCLA Cardiometabolic Research Center, and NIHsponsored Specialized Centers of Research Excellence (SCORE) in Metabolic Health. ITPM mentors direct
highly competitive research programs securing over $50 million per year in NIH funding. UCLA boasts one of
the most successful physician-scientist training pipelines centered around the Specialty Training and Advanced
Research (STAR) Program. STAR offers intensive research training, often leading to a PhD degree, combined
with clinical fellowship and early faculty support. The STAR program interfaces with the highly successful UCLACaltech Medical Scientist Training Program (MSTP), and both programs are directed by ITPM faculty ensuring
continuous mentoring through a vertical pipeline.
Over the past decade, the David Geffen School of Medicine (DGSOM) has invested over $25 million in
infrastructure, capital equipment, and new academic hires in metabolism-related fields. Strengths of the ITPM
program include: (a) established pool of talented and highly trained MD and PhD fellows; (b) accomplished and
caring mentors, including early-mid career faculty performing basic, clinical and translational research; (c)
leading-edge didactic lectures, seminars and symposia related to diabetes, obesity and metabolism; (d)
thoughtful training in research integrity and career development; and (e) major commitment from the DGSOM
and UCLA DoM to support the ITPM mission. The creation of the ITPM leverages unique resources at UCLA to
generate premier cohorts of highly trained physician-scientists driving important discoveries and leading-edge
evidence-based clinical care to improve human health

Public health relevance
UCLA Interdisciplinary Training Program in Metabolism PROJECT NARRATIVE Metabolic-related disorders including obesity, diabetes, and cardiometabolic disease challenge the health and welfare of our nation and are a leading cause of death worldwide. Despite considerable advance in basic and clinical research, many unanswered questions regarding the pathobiology of metabolic-related disorders and limitations in current treatment strategies hamper efforts to reduce metabolic disease burden. The Interdisciplinary Training Program in Metabolism (ITPM) leverages unique resources at UCLA to generate premier cohorts of highly trained physician-scientists driving important discoveries and leading-edge evidence- based clinical care to improve human health.